Decoding regulation of glucose homeostasis and metabolic responses to mitochondrial stress by AMPK

Project Summary/Abstract
High fasting plasma glucose and body mass index ranked 3rd and 4th, respectively, as global mortality risk factors
in 2017. Metabolic dysfunction links these factors with modern disease epidemics such as Type 2 diabetes
(T2D). Many current therapies and therapeutic development programs focus on symptoms rather than underlying
metabolic dysfunction common among these diseases. A primary goal of this work is to define mechanisms
driving maladaptive metabolism to develop more effective therapeutic strategies with potential for multi-disease
applicability. Mitochondrial impairments (e.g. inefficient oxidative metabolism and insufficient mitochondrial
quality control) are hypothesized as major pathologic components in these diseases. Therefore, understanding
mechanisms of mitochondrial regulation in conjunction with defective metabolism in diseases is a means towards
improving disease treatments going forward. AMP-activated protein kinase (AMPK) is a central regulator of cell
metabolism and multiple aspects of mitochondrial biology. Deficient AMPK signaling often overlaps the
pathological profile of mitochondrial impairments in disease. However, understanding whole-body effects of
deficient AMPK signaling as a multi-faceted driver of metabolic dysfunction and disease has been hampered by
lack of viable mammalian models. Organ-specific loss of AMPK mouse models have been critical for dissection
of metabolic implications of AMPK for individual cell types in vivo, but do not address multi-organ defects in
AMPK signaling that has been associated with insulin resistance and T2D. Additionally, developmental whole-
body knockout of AMPKα1 and AMPKα2 catalytic subunits (AMPK-DKO) causes in utero lethality in mice. To
address these issues, the first mouse model for inducible, whole-body AMPK-DKO (iAMPK-DKO) has been
generated. This model circumvents lethality of developmental AMPK-DKO and recapitulates disease-relevant
multi-organ defects in AMPK signaling. Preliminary data from this model demonstrate deficient glucose
homeostasis that is relevant to the study of T2D including postabsorptive hyperglycemia and glucose intolerance
as well as a seemingly paradoxical fasting induced hypoglycemia. Additionally, combining iAMPK-DKO with
genetically induced chronic mitochondrial stress in mice results in unique metabolic profiles, which are likely
relevant to glucose control. The PI for this project has extensive expertise with decoding in vivo metabolic
physiology. Combining this expertise with assessment of organ-specific mitochondrial function in acutely isolated
primary models, culture of organ-specific primary cells, molecular manipulation of gene expression, and confocal
microscopy of cellular systems will enable testing of this proposal’s central hypothesis: AMPK preserves
mitochondrial metabolism to maintain normal physiologic glucose homeostasis and enables metabolic
flexibility to preserve glucose homeostasis during chronic mitochondrial stress. Testing this hypothesis
offers insight in to the role of AMPK in glucoregulatory physiology and begins to decode the mechanisms by
which AMPK supports glucose homeostasis in normal physiology and pathologic mitochondrial stress.

Public health relevance
Project narrative Overnutrition and increased median lifespan have combined to drive epidemics of chronic metabolic disease including type 2 diabetes (T2D) and cardiovascular disease (CVD), which are linked by mitochondrial dysfunction and deficient AMPK signaling. Understanding mitochondrial control by AMPK in the context of in vivo glucose homeostasis and mitochondrial stress of aging serves progress towards pleiotropic treatments in these diseases. As a means towards this therapeutic goal, I will assess in vivo metabolism, implement multiple modes of mitochondrial assessment, and determine mechanistic targets of AMPK relevant to these contexts in novel mouse models lacking whole body AMPK activity in the presence and absence of chronic mitochondrial stress.